Vanderbilt Genome-Electronic Records (VGER) Project

It is critical to collect gender identity data to ensure affirming and equitable genetics care for transgender,
gender diverse, and sex diverse (TGSD) patients. Further, a person’s phenotypic sex (expression of primary,
secondary, and endocrinological sex characteristics), chromosomal sex, and organ/tissue inventory can
directly impact crucial aspects of testing and care recommendations. However, TGSD individuals can
experience psychosocial and clinical harms if gender/sex data collection and related care are not culturally
competent and accurate. Realistic fears about such harms could deter TGSD individuals from participating in
clinical research, and enrolled TGSD participants may experience harms from participation if data models and
study processes do not appropriately account for these variables. Automated processes are increasingly used
to streamline care and reduce health system burden, yet these processes increase the risk of misgendering
participants or providing clinically inappropriate recommendations if these data are not accurate. The
Electronic Medical Records and Genomics (eMERGE) Network is collecting sex/gender data at two points with
different question/response options, offering an opportunity to evaluate the impact of a large electronic health
record (EHR)-integrated genomics research study on TGSD individuals. The Network is evaluating the
influence of a novel EHR-integrated integrated genome-informed risk assessment (GIRA) report on clinical
care in 25,000 patients across 10 sites. The GIRA relies on data in the sex field to automate inclusion of
recommendations on the report for certain conditions, and as a result has the potential to negatively impact
TGSD participants. In this supplement application to the Vanderbilt Genome-Electronic Records (VGER)
Project, which supports the Vanderbilt University Medical Center site of the eMERGE Network, we will use in-
depth semi-structured qualitative interviews to investigate the impact of the eMERGE data collection, data
usage, and processes on the validity of the GIRA for TGSD individuals and on potential psychosocial and
clinical harms from the study on this population. We will use information gleaned in these interviews to develop
a best practice guide for genomics research involving TGSD populations and propose a model for data
collection that can support such research while remaining culturally competent and accurate. This model will
be included in the FHIR specification for the GIRA. This supplement directly supports the overall project goals
to validate and improve upon the GIRA.

Public health relevance
PROJECT NARRATIVE The eMERGE Network is evaluating a new risk report that combines risk information from clinical data, family history, and genetic testing in 25,000 individuals enrolled across 10 sites. Sex data affect the information included in the risk report, and it is possible that people who are transgender, gender-diverse, or sex-diverse (TGSD) could receive results that are not clinically accurate or culturally competent. In this supplement, we will investigate TGSD eMERGE participant experiences in qualitative interviews to help design more accurate and inclusive studies for TGSD people.